SAFETY AND EFFACY OF IRBESARTAN IN HYPERTENSIVE TYPE II DIABETICS

This study will ascertain the safety and tolerability of irbesartan, an angiotensin II receptor antagonist, in hypertensive subjects with type II diabetes mellitus and proteinuria.